San Antonio Program for Undergraduate Research in Renal Science (SPURRS)

This proposal seeks to continue the SPURRS (San Antonio Program for Undergraduate Research in Renal
Science) at the University of Texas Health San Antonio Long School of Medicine to attract promising
undergraduate students and recent graduates from diverse backgrounds to pursue careers in kidney research.
Kidney disease affects approximately 15-20% of the US population and accounts for ~16% of Medicare
expenditures each year. New therapies to stem the suffering and expense associated with kidney disease have
been slow to develop and will require a robust, diverse research workforce. At the same time, interest in
nephrology careers has plummeted, with the number of applicants for nephrology training programs remains
substantially below the number of training positions available. Efforts are desperately needed to cultivate the
next generation of kidney researchers and reverse this trend. Established in 2019, the Aim of the SPURRS
Program is to address this need by providing outstanding and motivated undergraduate students with an
immersive 10 week mentored summer research experience supplemented by a kidney research and career
development curriculum. At the end of their research experience, students will present the results of their
projects to their peers from the other R25 centers and NIDDK officials at the annual KUH Summer Student
Research Symposium. Together, these activities will expose students to the exciting world of kidney research
and provide them with a knowledge base, critical thinking skills, personal development tools and an enthusiasm
for discovery. These attributes are critical for their development into biomedical researchers and contributing to
the future of nephrology, which is the long-term goal of SPURRS. Results from the current funding cycle show
that we are able to recruit an outstanding and diverse group of students who subsequently have a high rate
(80%) of progression towards careers in medicine and biomedical research. The Aims of the proposal are to: 1.
Recruit a cohort of highly qualified and enthusiastic students, 2. Provide a hands-on research experience
through which students will learn how discovery, clinical and translational kidney research are conducted and
the results are disseminated to others, and 3. Provide mentoring and career development activities to enhance
entry and retention of the students into careers as kidney research scientists. We are uniquely positioned to
achieve the goals of our Program. UT Health San Antonio has a robust portfolio of kidney research programs
through which students will gain exposure to cutting edge research, a cadre of experienced mentors to guide
and energize students about careers in biomedical investigation, a location in a large, growing city with a large
population of URM students, and a PI with experience in leading R25 undergraduate research education
programs.

Public health relevance
The SPURRS program will result in greater participation in kidney-related research by young scientists and physician-scientists. This participation will benefit society as a whole by enhancing the research workforce, including under-represented minorities, to solve pressing problems brought on by the increasing burden of acute and chronic kidney disease.